Outreach, Recruitment and Engagement Core

OUTREACH RECRUITMENT & ENGAGEMENT CORE (ORE) PROJECT SUMMARY/ABSTRACT
The ORE plays an essential role in achieving the proposed goals of the Columbia ADRC by meeting the
outreach, engagement, recruitment and retention needs of the ADRC, focused especially on our local Northern
Manhattan community. In the previous cycles of the Columbia ADRC, the ORE Core has successfully met
recruitment, outreach, and engagement goals, including the recruitment of ADRC participants from traditionally
underserved and understudied populations that reflects the diverse population of Northern Manhattan. In the
current application, the Columbia ADRC will focus on investigating Alzheimer’s disease (AD)-associated
biological pathways. Accordingly, we will prioritize the collection of biomarker data in the ADRC including
cerebrospinal fluid (CSF) and MRIs, posing new challenges for the ORE Core. To help meet these challenges,
and to continue to meet the outreach, recruitment, and engagement needs of our local Northern Manhattan,
larger New York, and national communities, we propose five initiatives: 1. Leveraging existing Columbia
recruitment resources. Columbia has several NIH-funded aging and dementia research and clinical programs
that we will collaborate with that have developed extensive recruitment programs; 2. Increasing community
outreach, including a new relationship with the largest Heathcare Workers Union in New York, and the
development of a new Community Advisory Board to assist us with planning and executing community
outreach; 3. Improving metrics and data management. In conjunction with the Data Management Core, we
propose to utilize a new registry of potential participants, including information that will allow us to determine
the relative recruitment success of different outreach activities; 4. Exploration of the ethical and logistic aspects
of return of biomarker results to research participants in conjunction with the Biomarker and Clinical Cores and
the Columbia Center for Research on Ethical, Legal & Social Implications of Psychiatric, Neurologic &
Behavioral Genetics; and 5. Increasing community education by expanding our English and Spanish
educational materials, especially materials on the risks, benefits, and information gained, by CSF, MRI, and
PET biomarkers. We are confident that the Columbia ADRC ORE Core can continue to meet the evolving
needs of the Columbia ADRC, including the continued involvement, engagement, and recruitment of
participants from traditionally underserved and understudied populations, and the outreach and engagement
needs of Northern Manhattan, the larger New York area, and the larger scientific community investigating
Alzheimer’s disease and related dementias.